Multi-modal magnetic resonance imaging in progressive supranuclear palsy (PSP)

PROJECT SUMMARY/ABSTRACT
This is an application for a Mentored Patient-Oriented Research Career Development Award (K23). The goal
of the proposed project is to provide the candidate with skills necessary to develop an independent research
program dedicated to the development of neuroimaging biomarkers in Progressive Supranuclear Palsy (PSP)
and other Alzheimer disease-related dementias. To facilitate this long-term career goal the candidate will: 1)
identify multimodal (volumetric, structural and functional connectivity) magnetic resonance imaging (MRI)
differences among 3 PSP subtypes (PSP-Richardson syndrome (PSP-RS), PSP-Speech/Language Disorder
(PSP-SL), and PSP-Corticobasal syndrome (PSP-CBS)) as delineated in the recently revised PSP diagnostic
criteria, and 2) examine the associations between these imaging features with cross-sectional characteristics
and 1-year clinical change. The candidate proposes a comprehensive training plan, combining formal
coursework, meetings and tutorials overseen by his mentors, participation in applied training experiences, and
involvement in seminars and workshops. Specific training goals include: 1) training in neuroimaging methods
and image analysis; 2) advanced training in experimental study design and statistical analysis; 3) advanced
training in clinical trials methodology; 4) training in manuscript preparation, grant writing and leadership
capability; and 5) continued training in the responsible conduct of research. The training plan will be
implemented in coordination with a research project based on preliminary data collected by the applicant. The
primary hypotheses to be examined are: 1) In PSP-RS, there will be greater structural and functional
connectivity disruptions in bilateral dorsal midbrain and frontostriatal gray matter compared with other PSP
subtypes, and significant associations between baseline bilateral diffusion tensor imaging (DTI) dorsal
midbrain/resting state-fMRI (rs-fMRI) frontostriatal connectivity and executive function; 2) In PSP-SL, there will
be greater structural and functional connectivity disruptions in the dominant inferior frontal cortex and its
subcortical speech network connections, and significant associations between baseline DTI and rs-fMRI
measures in the dominant inferior frontal lobe and language function; and 3) In PSP-CBS, there will be greater
structural and functional connectivity disruptions in the parietal lobe-dorsolateral striatum network contralateral
to the most affected side, and significant associations between baseline DTI and rs-fMRI measures in the
parietal lobe-dorsolateral striatum and praxis. Results from this research will be used to develop a R01
research proposal that will facilitate the candidate’s transition to an independent researcher.

Public health relevance
PROJECT NARRATIVE The aim of this study is to better characterize brain imaging abnormalities and their relationship to clinical features in three subtypes of Progressive Supranuclear Palsy (PSP). This research will impact public health by providing noninvasive biomarkers of PSP subtypes that may improve diagnostic accuracy and serve as outcomes in clinical trials for PSP and other Alzheimer disease-related dementias.